On-site, high-fidelity target sequencing and absolute quantitation for HIV-1 surveillance

PROJECT SUMMARY / ABSTRACT UNAIDS has set ambitious 90/90/90 targets toward ending the HIV/AIDS epidemic: that by 2020, 90% of people living with HIV will know their HIV status; 90% of those diagnosed will be on sustained antiretroviral treatment; and 90% of those on treatment will have achieved viral suppression. Reaching these goals will require precise and efficient testing, patient care, and prevention interventions for key populations, particularly in resource-limited settings. The genetic diversity of microbial pathogens — not just HIV-1 but any number of pathogens for which antimicrobial drugs are being developed/employed — remains a major challenge for those endeavoring to control them. Drug-resistance surveillance and the genotyping of microbial pathogens have long been plagued by limited read lengths and erroneous sequencing. The proposed project will develop an innovative sequencing and quantitation platform technology that can sensitively detect and accurately delineate HIV-1 variants in patients through barcode-mediated, whole-genome sequencing using the so-called “third-generation” Nanopore sequencing technology (Aims 1 and 2). Taking advantage of the pocket-size mobility of the MinION Nanopore sequencer and other portable biotechnology devices that have recently became available, we will further develop this technology for on-site and real-time surveillance and drug- resistance diagnosis of emerging viruses even in resource-limited settings (Aim 3). Successful completion of this study will produce a low-cost, ultra-high-accuracy sequencing and quantitation technology with broad applicability to problems in diverse areas of science and medicine, from de novo genome assembly to point-of- care drug-resistance genotyping. HIV-1 offers an excellent testbed for this technology due to the high degree intra-patient genetic diversity and the need for on-site and genome-wide genotyping.

Public health relevance
PROJECT NARRATIVE On-site, high-accuracy drug resistance surveillance for microbial pathogens is of substantial importance for effective patient care and for the effective control of infectious diseases, particularly in resource-limited settings. We propose to develop an innovative on-site, ultra-high-accuracy sequencing and quantification technology for point-of-care diagnosis and real-time surveillance of drug-resistant HIV-1 viruses. Successful completion of this study will produce a low-cost, portable sequencing and quantitation technology that may prove groundbreaking for biomedical sequence analysis, providing a novel means of resolving key issues in broad areas of science and medicine.